Building a Multidisciplinary Research Program to Address Hypertension Disparities:Exploring the Neurocognitive Mechanisms of a Self-Management Intervention for African American Women with Hypertension

PROJECT ABSTRACT
With a continued increased in the diagnosis and prevalence of hypertension among African American women,
this group is particularly vulnerable to stroke, end-stage renal disease, and premature death. Although there
are interventions available to help patients manage chronic disease, there is significant variability in blood
pressure control among African American women. Current approaches to aid patients in making lifestyle
changes have primarily been “one size fits all” methods. Self-management behaviors require cognitive effort –
for planning and goal-setting, these factors are associated with distinct patterns of brain activity, referred to as
“neuroprocessing.” The relationship between neuroprocessing and self-management behavior is poorly
understood. Findings from our pilot studies show a large correlation between health information behavior
(information sharing) and activation in the default mode network (comprised of the medial parietal and
prefrontal cortices, and temporo-parietal junctions and responsible for social and emotional modes of thought)
and the ventromedial prefrontal cortex (shown to mediate links between social connection and health). A better
understanding of how brain activity (ability to differentiate between neurological prompts) changes in response
to our hypertension education programs will improve the precision and tailoring of self-management
interventions. The objective of this project is to develop and pilot test a newly designed, health information
behavior enhanced intervention to improve self-management of hypertension in African American women.
Using functional magnetic resonance imaging, or fMRI, we will examine brain activity (default mode network
vs. task positive network) in response to video prompts. We will assess the influence of the intervention on
neurocognitive processes associated with self-management in a subset of the sample to explore the
neurobiological mechanisms underlying the intervention. This work will contribute to the reduction of the
tremendous health disparities affecting African American women. The findings will be used to support future
studies examining the effects of our information sharing intervention in a larger sample of African American
women with hypertension.
Dr. Jones's program of research is focused on designing and testing self-management interventions to improve
blood pressure control among African American women, as well as detailing the individual neuroprocessing
profiles associated with successful response to such interventions. The training and mentoring plan will
promote development in three areas: 1) intervention design and testing, 2) cognitive neuroscience, and 3)
grantsmanship. This multidisciplinary team of experienced mentors and advisors will oversee a range of
training and research activities in these areas to ensure Dr. Jones's future success. The exceptional resources
of a top university and a mentoring team with proven success in developing junior faculty in these topic areas
make the University of Michigan an ideal environment for Dr. Jones's project.

Public health relevance
PROJECT NARRATIVE The goal of this project is to develop and pilot test a research protocol to assess the influence of a health information behavior enhanced intervention on self-management, blood pressure control, and brain activity in African American women with hypertension. This work will identify characteristics of African American women that are associated with improved self-management and decreased blood pressure, and subsequent reduction of risk of heart disease and premature death. The results of this project will have direct impact in informing interventions to improve blood pressure control, by advancing our knowledge of brain activity associated with behavior change in African American women with hypertension in the metro-Detroit area, and ultimately everywhere.